Genomic-based diagnostics for Coccidioides the causative agent of Valley fever

Program Director/Principal Investigator (Last, First, Middle): Keim, Paul 1 R01 AI076773-01 No Text

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Keim, Paul 1 R01 AI076773-01 No Text